Allopurinol Improves Diastolic Function in African Americans with Resistant Hypertension

Heart failure (HF) is a leading cause of morbidity, mortality and escalating health care costs within the VA. The
type of HF that is increasing disproportionately is HF with a preserved ejection fraction (HFpEF), commonly
caused by hypertension and left ventricular (LV) pressure overload. An estimated 10% to 20% of hypertensive
patients have resistant hypertension (RHTN), defined as having controlled or uncontrolled blood pressure with
the use of ≥ 3 medications that includes a diuretic. We previously reported significant LV hypertrophy and
diastolic dysfunction with normal systolic function in persons with RHTN. Hypertension among Black adults in
the US has one of the highest prevalence rates in the world and is related to adverse changes in LV structure
and function. Hypertension is an underlying factor in >50% of Black adults with HF and is the strongest risk
factor for HF in that population.8 Black adults have a 50% increased incidence of HF, due in large part to the
greater prevalence and severity of hypertension, and HF occurs 8 years earlier in Black adults as compared
with Whites. Although Black adults have the highest death rate for HF, they are consistently underrepresented
in clinical trials. The greater HF burden among Black adults calls for further work to discover effective
preventive and therapeutic strategies for this higher-risk population. The greater HF burden among Black
adults calls for further work to discover effective preventive and therapeutic strategies for this higher-risk
population. The long-term goal of this project is to develop an effective strategy to improve the health of African
American Veterans with HFpEF. We have recently reported increased plasma xanthine oxidase (XO) activity
and mtDNA damage associated molecular products (DAMPs) levels in Black adults with RHTN, compared with
White adults with RHTN. This supports the general consensus that oxidative stress is higher in black adults.
XO oxidizes hypoxanthine and xanthine to generate hydrogen peroxide and superoxide as a byproduct. These
products damage mitochondria leading to bioenergetic dysfunction and further amplification of oxidant
generation and production of mtDNA DAMPs. mtDNA DAMPs are potent activators of the innate immune
response through several pathways including activation of TLR (toll-like receptor) with promotion of pro-
inflammatory cytokine release. We have shown diastolic blood pressure (r=0.876, p<.001), LV end-diastolic
mass index (r=0.503, p=0.012), fractional shortening (r=-0.546, p=0.006), wall thickness (r=0.428, p=0.001),
mid-wall radius to wall thickness ratio (r=0.354, p=0.008), and early diastolic filling rate (r=-0.422, p=0.04) were
related to XO activity at six months among the Blacks but not White RHTN patients. Given the higher level of
XO activity and mtDNA DAMPs in blacks, we hypothesize that inhibition of XO improves LV diastolic
function in Black African Americans with RHTN. We will address this hypothesis in the following Aims.
Aim 1. Impaired LV diastolic function is a major cause of symptoms in HFpEF. Therefore, we will test the
hypothesis that allopurinol improves LV diastolic function using CMR as previously performed in our lab. Aim
2. Impaired LV diastolic function is linked to decreased exercise capacity and quality of life. Therefore, we will
test the hypothesis that Allopurinol therapy will improve exercise capacity in a six-minute walk test and quality
of life using the Kansas City Heart Failure Questionnaire.

Public health relevance
Black adults in the US have the highest prevalence rate of hypertension and heart failure in the world. Blacks have higher xanthine oxidase activity than Whites. This grant will measure left ventricular function with cardiac magnetic resonance imaging after blockade of xanthine oxidase with allopurinol in Black Veterans.